Clonal Hematopoeisis, Biomarkers of Aging and Cancer Risk for People Living With HIV (HIV-Associated Cancers in Aging Populations)

Summary
Clonal hematopoiesis (CH) is the presence of a proportion of hematopoietic cells carrying a somatic mutation
that arise from a common hematopoietic stem or progenitor cell (HSPC). CH increases with aging and is an
independent risk factor for hematologic malignancy as well as cardiovascular disease and all-cause mortality in
the general population. People living with HIV (PWH) are at increased risk for many age-related comorbidities
including cancer and CH is of emerging interest in this population as a potential prognostic biomarker. Several
studies have identified a higher prevalence of clonal hematopoiesis of indeterminate potential (CHIP) in PWH
compared to non-HIV matched comparators. For PWH, the intersection of genomic alterations with the persistent
immune activation and inflammation characteristic of HIV infection posits a complex interplay that may accelerate
aging processes and predispose individuals to age-related diseases at a higher rate than the general population.
Given that PWH are at higher risk of CHIP, we propose to investigate whether CHIP could be mediating both
accelerated biological aging and downstream cancer events. We hypothesize that PWH will have a higher
prevalence both CHIP and methylation markers of aging than matched controls and that both will be independent
risk factors for incident malignancy in PWH. Here we propose to (1) compare the prevalence of CHIP by HIV
status in a health system-based cohort, (2) compare epigenetic age in a large cohort by HIV status and presence
of CHIP and (3) to assess the effect of CHIP and biomarkers of aging on aging on cancer incidence and outcomes
in PWH. This work will elucidate the potential interplay between CH, aging and cancer in PWH and facilitate the
establishment of CH as a biomarker for potential preventive intervention within this population.

Public health relevance
Narrative Persons with HIV have an increased risk of Clonal hematopoiesis of Indeterminate Potential (CHIP) which is the presence of a proportion of blood cells carrying a somatic mutation that have all arisen from a common blood stem or progenitor cell. CHIP is hypothesized to be a biomarker of accelerated aging and may increase an individual’s risk for developing cancer. In this study, we will evaluate the prevalence of CHIP and methylation markers in PWH and their potential association with cancer.